Role of opioid-glutamate interactions in intrinsically rewarded social behaviors

The proposed studies will uncover components of a core neural system that underlies affiliative, rewarding,
non-sexual social communication. In cases of depression, anxiety, and autism spectrum disorders, social
interactions that are typically rewarding can become aversive. Deficits can also be context-specific. For
example, some autistic individuals are able to make directed requests (e.g., for food) that can be extrinsically
reinforced (e.g., by receipt of food) but exhibit profound deficits in affiliative communication (e.g., nonsexual,
chitchat) that promotes social bonds and is rewarding but does not result in an immediate, obvious extrinsic
reinforcer. Many studies focus on mechanisms underlying goal-directed, extrinsically rewarded behaviors (e.g.,
food-, mate-, or drug-directed); however, these mechanisms appear to differ from those underlying intrinsically
rewarded, affiliative social behaviors, leaving a critical gap in basic knowledge about mechanisms underlying
non-sexual, affiliative communication. Studies taking advantage of the unique communication properties of
songbirds reveal a previously unappreciated role for the medial preoptic nucleus (mPOA) and in particular mu
opioid receptors (MORs) in the mPOA in both facilitating and rewarding a form of non-sexual, affiliative singing
behavior. Preliminary RNAseq data reveal for the first time a complex of glutamatergic genes in mPOA to be
tightly associated with this type of song. The objective of this application is to integrate findings related to the
essential role of glutamate and glutamate-MOR interactions in reward to identify foundational, understudied
biological mechanisms that underlie affiliative, rewarding communication. The central hypothesis is that
glutamate-related genes and MOR-glutamate interactions in the mPOA play critical roles in affiliative
communication and other social interactions. The rationale is the need for basic, mechanistic information on
core social circuits that underlie behaviors disrupted by mental illness. Based on past and preliminary data, two
specific aims are proposed: 1) Determine selective contributions of glutamate-related genes in mPOA to
affiliative song, social motivation, and reward; 2) Explore the role of MOR-glutamate interactions in mPOA in
affiliative song and reward. In Aim 1 shRNA will be used to knockdown glutamate-related genes SHANK2,
GRM5 or GRIN1 in mPOA or a control region, and affiliative song, other social behaviors, social motivation,
and social reward will be tested. In Aim 2 effects of the same manipulations on the ability of pharmacological
MOR stimulation to facilitate affiliative song as well as reward will be tested. The approach is innovative
because it advances the understanding of intrinsically-rewarded social behavior in songbirds with the goal of
identifying fundamental, conserved mechanisms. The proposal is significant because it will elucidate the role of
glutamate-related genes and MOR-glutamate interactions in non-sexual, affiliative social behaviors and provide
insight into core neural circuits that may be disrupted by mental illness in humans.

Public health relevance
The proposed research is relevant to public health because it will fill a gap in knowledge about neuromodulators and brain regions involved in affiliative, non-sexual, positive social behaviors, which are disrupted by multiple mental health disorders. This project is relevant to NIMH’s mission, as knowledge about basic mechanisms underlying these types of social behaviors is crucial to develop treatments that can restore the positive, affiliative social interactions that are devastated by mental illness.